Immune Function and the Progression to Type 1 Diabetes

Type 1 diabetes (T1D) is a disorder that arises following the autoimmune destruction of insulin producing
pancreatic β-cells. Previous studies, including nearly 120 peer reviewed-articles supported by this P01 over the
current grant cycle, have demonstrated that individuals with or at increased-risk for T1D display a series of innate
and adaptive immunological abnormalities linked to genetypes at >150 risk-associated loci. Indeed, these efforts
have identified a series of immune dysfunctions associated with T1D that are strongly influenced by genetics
(e.g., loss/gain of function mutations, promoter/enhancer variants, shifts in exon usage) and appear to drive
autoimunity. Yet the complex contributions of T1D-risk loci to these processes remain quite unclear. Thus, our
goal in seeking renewal of this P01 is to elucidate the mechanisms by which T1D-associated variants across the
genome (Project 1), and specifically (SH2B3 [Project 2], HLA-II region, SIRPG, CD226 [Project 3]), impart
phenotypic and functional immune defects. The research proposed will collectively test two overall hypotheses—
1) the impact of T1D-risk variants will vary by tissue, cell subset and activation state, and 2) risk variants, cellular
stress, and defects in immunologic pathways are key to engender the autoimmune destruction of pancreatic -
cells that results in T1D. The three separate but highly interactive Projects have a strong history of sharing data,
using innovative technologies, and assessing fresh and cryopreserved samples from well characterized human
subjects with or at risk for T1D, as ascertained through two Core facilities: Core A– Administrative/Sample
Acquisition and Core B– Biobank/Biostatistics/Bioinformatics. Project 1 will implement our novel pancreas slice
culture system and TCR-redirected “avatars” to evaluate the impact of inflammation in the target organ. Project
2 will use genotype selected UFDI Study Bank samples (Core B), pancreas tissues, and differentiated gene-
edited iPSCs to interrogate how SH2B3 allotypes impact innate immune cell function, T cell activation, and
trafficking through inflamed vasculature. Project 3 proposes to study pancreatic lymph node (pLN), spleen, and
peripheral blood to test the hypothesis that T1D-associated genetic risk variants alter the TCR repertoire and
gene expression pathways in a cell- and tissue-restricted manner. These proposed studies are further supported
by the rich environment for T1D research at the University of Florida that includes resources such as pancreatic
and lymphoid tissue samples from the Network for Pancreatic Organ donors with Diabetes (nPOD), interactions
with major clinical trial networks including T1D TrialNet, and special efforts related to the impact of race/genetic
ancestry (made possible through highly active recruiting efforts) on T1D heterogeneity. The successes expected
from the proposed studies should provide: 1) novel insights into the immune and genetic influences that
contribute to T1D; 2) novel biomarkers for disease susceptibility and autoimmune activity associated with the
disease; and 3) could dramatically improve prospects for the development of an effective therapeutic capable of
preventing and/or reversing T1D.

Public health relevance
P01 Narrative Type 1 diabetes (T1D) is an autoimmune disorder that not only imparts a considerable adverse impact on daily lifestyle but also, over a lifetime, often results in patients that succumb to a series of debilitating disease- associated complications and early mortality. The studies proposed in this P01 are designed to better understand the contributions of genetics to the coordinated immune response that mediates T1D development, through studies of the human pancreas, trafficking through inflamed vasculature, and phenotype/function relationships within the pancreatic draining lymph nodes and peripheral blood samples. We expect knowledge gains from these studies will lead to the identification of improved biomarkers of disease activity, and uncover precision- medicine based targets for therapeutic interventions capable of preventing or reversing T1D autoimmune pathogenesis.